Dual Functionality of Ceramide in Human Microvascular Endothelial Function

Project Summary
Elevated levels of plasma ceramide are an independent risk factor for major adverse cardiac events (MACE)
and are associated with cardiovascular diseases including coronary artery disease (CAD) and heart failure with
preserved ejection fraction (HFpEF). Endothelial microvascular dysfunction, the loss of nitric oxide (NO)-
mediated dilation to flow (flow-induced dilation; FID), precedes the development of CAD and occurs following
chronic exposure to exogenous ceramide. During disease, following acute stress (e.g. high pressure), or after
chronic ceramide treatment, FID is maintained by utilizing mitochondrial-derived hydrogen peroxide (H2O2).
Although effective at eliciting dilation, unlike the anti-inflammatory effects of NO, H2O2 promotes an inflammatory
environment within the vasculature and surrounding parenchymal tissue. The mechanism(s) by which ceramide
promotes mitochondrial H2O2-mediated FID remains unknown. Interestingly, ceramide has also been implicated
as a critical signaling component in the generation of NO. The ceramide metabolite sphingosine-1-phosphate
(S1P) exerts opposing effects on the endothelium, promotes the formation of NO, and may explain the positive
vascular effects associated with ceramide. A large knowledge gap exists regarding the dual functionality of
ceramide within the human microvascular endothelium. We hypothesize that while ceramide formation is a
critical mechanistic component in NO-mediated FID, prolonged exposure initiates a signaling cascade that
results in the release of mitochondrial H2O2 in response to shear. Our aims are as follows; 1) determine the
necessary role of ceramide in maintaining NO-mediated FID within the human microcirculation, and 2)
investigate the mechanism(s) by which ceramide formation during stress or disease initiates the transition in FID
mediator from NO to mitochondrial-derived H2O2. Using a novel approach, these mechanistic studies will be
complemented by the first human in vivo study to examine the effect of elevated plasma ceramide on peripheral
microvascular function. The translational studies proposed in this application will enhance our understanding of
ceramide signaling during health, disease, and following acute stress. This information will provide new targets
for therapeutic intervention in individuals at risk for developing cardiovascular disease including CAD and
HFpEF.

Public health relevance
Sphingolipids can promote or prevent microvascular endothelial dysfunction, which precedes large artery atherosclerosis. We hypothesize that formation of ceramide, although detrimental following chronic exposure, is necessary for proper microvascular function. The results of this study could greatly expand our understanding of local tissue perfusion and provide novel targets for the treatment of cardiovascular disease.